Involvement of Noncanonical Short RNAs in Gene Repression through the RNA-Induced-Silencing Complex

ABSTRACT:
Funded by the parental R01, 5R01GM146756, we have been studying the regulation of a novel family
of short RNAs and their functions. These studies require us to prepare carefully size-selected cDNAs
that are derived from short RNAs of specific lengths. This proposal is for an equipment supplement that
will enable us to purchase a newly available piece of equipment, PippinHT, to more efficiently prepare
size-selected cDNA libraries to advance the specific aims of the parental R01.

Public health relevance
NARRATIVE: We will purchase a newly available piece of equipment, PippinHT, to more efficiently prepare size- selected cDNA libraries that will allow us to advance the specific aims of the parental R01, 5R01GM146756.